Leadership and Administrative Core

Project Summary/Abstract: LEADERSHIP AND ADMINISTRATIVE CORE
The goal of the Leadership and Administrative Core is to provide, not only administrative oversight of
the Center, but to also advance research in geriatric palliative care (GPC) and its translation through a
framework of connected activities that starts with creating a pipeline of trainees, supporting their research
development, and ends with efforts to disseminate the work to improve the lives of older persons and their
families. The core specific aims are to foster and support scientific innovation in GPC and to disseminate
research ready for clinical and policy translation; to assist and oversee the Research Education Component in
identifying, selecting, and monitoring junior investigators and their studies; to assist, oversee, and
coordinate 3 resource cores in identifying methodologic themes that will advance research in GPC; to
integrate activities and facilitate interchange in GPC among the OAIC cores and investigators; to coordinate
the OAIC’s work with research activities of other programs and institutions; and to provide administrative and
communications support, coordination of human subjects review, and fiscal management for the cores and
projects involved in this OAIC. In the renewal, we expand the size, and breadth of the OAIC’s leadership team
including a new MPI and new core leaders, continue and expand existing successful efforts of the OAIC
including our cross-cutting themes of dementia and implementation science, and add new innovative initiatives.
New to this renewal, we propose two changes to allow for better integration of inter-related activities while
reducing administrative costs and infrastructure. First, we have integrated our prior PESC into the REC given
the vast majority of pilot funding has gone to early-stage scientists. Second, we have created a new expanded
Resource Core – Research Methods and Measures (RC-RMM) that merges our prior Measurement, Methods,
and Analyses Core (RC-MMA) and Population Research and Methods Core (RC-PRM). RC-RMM and adds
qualitative and geospatial analyses resources. We also propose a new cross-cutting theme and resource core
focused on Health Disparities (RC-HD) that will leverage a range of existing data sources to support research
that will advance our understanding of health disparities in the longitudinal course of serious illness on older
adults and their caregivers. We have created new partnerships with OAICs to advance health services
research and enhance dissemination of OAIC research through the award winning GeriPal podcast. By
strategically leveraging resources from other programs, this core maximizes the impact of a modest investment
to create an OAIC that is comprehensive in scope, significant in local impact, collaborative with other OAICs
and NIA programs, and national in its reach.